Rho GTPase inhibitor for refrigerated platelet storage

SUMMARY
The use of platelet transfusions has increased dramatically since 1980s, but a safe, long-term platelet storage
method remains missing. Current practice has platelets stored at 20 to 24°C after preparation, which has a
limited lifetime up to 5 days primarily due to concerns about bacterial contamination, because cold storage of
platelets results in complex molecular lesions that are recognized by host macrophages and hepatocyte
counterreceptors, leading to phagocytosis and clearance upon transfusion. In prior NIH SBIR phase 1 funded
studies, we demonstrate functionally that murine, human and Rhesus-macaque washed platelets, when stored
in refrigerated conditions for 7-14 days in the presence of a reversible RhoA GTPase inhibitor, G04, can fully
maintain function to a level like that of room-temperature stored platelets. We hypothesize that reversible
inhibition of RhoA via the G04 pharmacologic inhibitor can be translated to a new regimen for safe, cost-efficient,
and fully functional long-term storage of platelets in refrigeration. This project will develop our product, the RhoA
inhibitor S-G04, an enantiomer of G04, in a Platelet Additive Solution contained in a medically available bag, for
human platelet cold storage up to 14 days. Based on a previous discussion with the US Food and Drug
Administration (FDA), we aim to assess the pharmacokinetics and ADME of S-G04 in our product and to
determine the GLP stability and safety of S-G04 in FDA IND-enabling studies. The deliverables will include an
established safety and efficacy of this product in a commercially available platelet storage PAS/bag, and that
this revolutionary technology can be available to all blood centers/hospitals needing PLT transfusion as a single
inventory, like that for plasma and red blood cell supplies.

Public health relevance
NARRATIVE Hematology/oncology and trauma patients with low platelet counts often require platelet transfusion, and this is crucial in the treatment of patients with cancer or hematologic diseases. The development of a method to prevent platelet damage upon refrigeration is a dream in blood banking and it would revolutionize the current method of platelet storage. The proposal intends to develop a method to store fully functional platelets by refrigeration and will move a novel regimen for platelet cold storage to FDA IND filing and commercialization.